Phase III Development of a Valid, Reliable, Clinically Feasible Measure of Transactional Success in Aphasic Conversation: Modernizing Methods of Acquisition and Analysis of Discourse Data

SUMMARY
Models for assessing and treating aphasia, a language disorder affecting at least 2.5 million Americans, have
gradually moved from an impairment-based to a participation-based framework. However, there exist no valid,
reliable, clinically practical tools for directly measuring gains in conversation, the most frequent communicative
activity of daily life in older adults. The long-range goal of the proposed study is to provide a theoretically
grounded, practical, automated tool for clinicians and clinical researchers to assess changes in transactional
success in conversation without transcribing and analyzing aphasic discourse, a time- and resource-intensive
skill that hinders the inclusion of conversational discourse in treatment outcomes. We propose to fill this gap
with the recently piloted Brief Assessment of Transactional Success in conversation (BATS). After watching
and/or listening to short (2.5 minute) BATS video/audio stimuli, people with aphasia (PWA) retell the story in a
monologic discourse task and then engage with a conversation partner who is naïve to the story, who then
retell the story. The objectives of the proposed study are twofold: Aim 1 will demonstrate the reliability of
the BATS and its validity in assessing transactional success. Reliability coefficients will be calculated for
alternate forms of the video/audio stimuli as assessed by core lexicons, main concepts and
comprehensiveness ratings. The magnitude of multiple potential sources of measurement error will be
estimated to identify optimal data collection conditions (e.g., conversation partner familiarity). Evidence of
converging and discriminant validation will evaluate the degree to which the BATS measures constructs such
as joint action, total communication, and context, the three core elements that characterize the situated
language use model of communication, and that enable PWA to communicate better than they talk. Aim 2 will
advance automated methods of studying discourse in aphasia. Text analysis tools from open-source natural
language processing platforms will interface with Python programs to assess core lexicons and topic similarity
in conversation partner story retells. Pilot data suggests that use of automated methods for assessing micro-
and macrolinguistic features of discourse to reveal transactional success in conversation in aphasia is feasible.
This research is innovative because it applies 21st century videoconferencing technology to deliver a novel
tool for assessing transactional success in conversation, while developing an automated software application
to make the tool accessible to clinicians and clinical researchers who serve PWA, even in remote areas. The
contribution is significant in that it will overcome a major obstacle in measuring real-world functional
response to therapy in aphasia. Incorporating the three levels of BATS discourse (PWA story retells, dyadic
conversations, and conversation partner retells) into AphasiaBank will create a rich, shared online database for
studying how PWA succeed in co-constructing meaning in conversation. This project reflects current priorities
in Areas 3 and 4 in the NIDCD strategic plan for Voice, Speech, and Language Research.

Public health relevance
PROJECT NARRATIVE People who live with aphasia, and other disorders affecting speech, language or communication, frequently experience social isolation and other negative psychosocial consequences that can exacerbate long-term disability. While life participation approaches to testing and treating these disorders seek to address them in real-world contexts, a major challenge to measuring conversational outcomes in efficacy research is the lack of a psychometrically robust and clinically feasible measure of change in conversation. Our goal is to create a free, accessible, web-based automated tool for the collection and analysis of story retelling using natural language processing of non-aphasic conversation partner discourse to directly reflect transactional success in conversation while reducing clinical workload.